Small Animal Studies

Abstract Shared Resource 11: Small Animal Studies (SAS-SR)
The Small Animal Studies Shared Resource (SAS-SR) comprises two components: the Small Animal Imaging
Core and the Animal Tumor Models component. This combined resource provides exceptional quality services
for City of Hope Comprehensive Cancer Center (COHCCC) Members for basic and translational preclinical
studies in cancer biology, anti-cancer drug development, and stem cell therapeutic development.
Specific Aims for SAS-SR:
Aim 1. Provide consultation for the design, performance, and analysis of animal experiments.
Aim 2. Facilitate the development of new animal models and novel non-invasive in vivo imaging
technology in support of cancer research.
Aim 3. Maintain the resources and expertise necessary for conducting animal research with high quality
standards and in compliance with local, state, and national guidelines.
The Small Animal Imaging component of the SAS-SR provides consultation, advanced imaging equipment,
imaging services, hands-on training for COHCCC Members, and support for protocol and grant preparation.
Current systems in the Imaging Laboratory include five units for bioluminescence/fluorescence optical imaging
(Lago/Lago X/Ami HTX from Spectral Instruments Imaging and a PerkinElmer IVIS), a GNEXT PET/CT
instrument (SofieBiosciences), a 7T MRI/PET (MRsolutions), and ultrasound imager (VisualSonics VEVO).
These systems support molecular-based imaging to allow for the monitoring of cellular processes and the non-
invasive assessment of pharmacokinetics and pharmacodynamics of therapeutic agents. The Animal Tumor
Models component of the SAS-SR has established patient-derived xenograft (PDX) models of multiple cancers
in collaboration with COH faculty and has developed next-generation humanized mouse models for research in
cancer immunotherapy and in vivo drug metabolism/toxicity studies. The development of PDX models supports
precision medicine allowing investigators to evaluate tumor growth and therapeutic response for individual
patients. The Animal Tumor Models component also provides specialized drug delivery services, training for in
vivo procedures, and support for protocol preparation and grant development. The SAS-SR is co-directed by Dr.
Anna Wu, Professor and Chair, Department of Immunology and Theranostics and by Dr. Jun Wu, an Associate
Research Professor of Comparative Medicine. Activities are supported by highly qualified personnel that
maintain and operate the instrumentation.
Members Utilization by %Revenue 2017–21: 96.7 Total (11.2 MCBC, 33.4 DCT, 26.6 CI, 25.5 HM)
Publications by Members: 88, 28 with Impact Factor >10
Grants Supported: 78 Total (3 ACS, 8 CIRM, 8 DoD, 4 LLS, 33 NCI of 46 NIH (32 R01, 1 U01))